Developing a platform for engineering customizable cell-cell signaling in vivo

Abstract. Synthetic biology combines biological and engineering principles to regulate cellular
processes, and is emerging as an important area of biomedical research. To date, synthetic biology has
focused largely on manipulating processes inside cells, most notably to control gene expression or
metabolism, and arranging them into modules that perform discrete functions. By contrast, current cell-
culture based synthetic approaches are ill-equipped to manipulate processes that control interactions
between cells to create desired outcomes at the tissue level, a capacity that would be of particular value
in the fields of tissue engineering and regenerative medicine. What is needed is a genetically tractable in
vivo platform within which synthetic cell-cell signaling tools can be rapidly created, tested, optimized and
diversified, before they are deployed and further refined in systems that have therapeutic and
biotechnological applications. We propose to fulfill this requirement by establishing a Drosophila system
for designing synthetic intercellular signaling that controls tissue behavior. We have developed prototype
synthetic ligand/receptor systems predicated on the basic mechanism of Notch activation, where
mechanical force exerted by ligand endocytosis induces the cleavage of an extracellular “force-sensitive”
domain of the receptor. We have paired our synthetic receptors with a new genetic protocol for controlling
ligand/receptor interactions, conducting functional screens and altering synthetic receptor outputs. First,
we will diversify our repertoire of synthetic receptors by conducting a large-scale screen for new
heterologous force-sensitive cleavage domains. Second, we will rigorously assess our new receptors for
their suitability to be used in circuits and characterize their important response parameters, such as the
potency of signal and capacity for regulation. Last, we will assemble circuits of synthetic signaling
modules to produce predictable outputs within an epithelial tissue. If successful, the proposed
experiments will be a significant step toward our long-term goal of establishing a tractable in vivo system
for developing cell-cell signaling technology that has future applications in tissue engineering and
regenerative medicine.

Public health relevance
Project Narrative Synthetic biology involves engineering cells so that they perform useful tasks and an ambitious aim of the field is to customize cell behavior so that they form tissues for the repair of wounds, correction of birth defects or regeneration of damaged limbs. Central to this goal is enabling cells to communicate using tailor-made components, and the proposed research is relevant to public health because it describes the development of a proving ground for devising and testing this synthetic cell communication technology. Thus, the research is relevant to NIH’s mission to reduce the burden to society arising from genetic and environmental disorders of fundamental aspects of human development and physiology.